Statins in Non-Ischemic Heart Failure: Potential Mechanisms of Benefit

[unreadable] DESCRIPTION (provided by applicant): Tamara Norwich (candidate) is an Assistant Professor at the University of California, Los Angeles. The candidate's long-term career goal is to be a clinician-investigator, focusing research in the area of heart failure (HF). Although the candidate has had experience and success with observational research in the HF field, her goal is to acquire the experience and skills to successfully and independently conduct prospective, experimental studies / translational research. UCLA is an ideal institution to commence a career in clinical cardiovascular investigation; the candidate will have the benefit of formal instruction through the Masters in Clinical Research Program via UCLA's Department of Biomathematics while working with excellent, dedicated mentors on a clinical study to investigate mechanisms of a potential new therapy for HF. The candidate's recent research suggests that HMG-Coenzyme A (statin) therapy is associated with improved survival in both ischemic and non-ischemic HF. Thus, the candidate is interested in investigating statins' potentially beneficial mechanisms of action in HF. The current project will study statins' effects on: 1) sympathetic nervous system activation 2) myocardial remodeling and 3) systemic inflammation. Fifty patients with systolic, non-ischemic HF will be randomized in a double-blinded fashion to 3 months of atorvastatin 10mg QD (25 subjects) vs matching placebo QD (25 subjects). The following exams will be performed both pre- and post- treatment phase: 1) sympathetic microneurography, for direct quantification of changes in sympathetic nerve activity, 2) cardiac imaging (echocardiography and MRI in a subset without pacemakers/defibrillators) to track changes in cardiac structure and function, and 3) peripheral blood analysis for candidate chemokines. Additional investigation will include studying effect of statins on cardiac biomarkers, arrhythmias, heart rate variability, and quality of life and global clinical assessment. Relevance: HF affects over 5 million people in the U.S., and only 50% survive at 5 years. The cholesterol- lowering drugs known as statins may improve the hearts' pumping function, as well as improve symptoms and survival HF, even in the absence of coronary artery disease. This study will investigate how statins may potentially benefit patients with HF, and thus may ultimately contribute to discovering new strategies to treat HF. (End of Abstract) [unreadable] [unreadable] [unreadable]